Extracranial Carotid Atherosclerosis Contributions to Cognitive Impairment and Alzheimer's Disease Risk

PROJECT SUMMARY/ABSTRACT
There is growing need to understand mechanisms and treatment options associated with vascular contributions
to Alzheimer’s disease (AD) and other forms of dementia and cognitive dysfunction. Early brain changes
associated with AD and other forms of cognitive dysfunction, such as white matter lesion (WML) burden,
hypoperfusion and metabolic mismatch have vascular risk factors (hypertension, diabetes, aging and smoking).
Such structural and functional brain changes are often considered secondary to intracranial cerebral small vessel
disease. In contrast, our preliminary data indicate that extra-cranial carotid artery disease (ECAD) contributes
to brain pathology and its treatment with carotid endarterectomy (CEA) (to surgically remove the plaque)
decreases accumulation of WMLs and neurofibrillary tangles, increases structural connectivity, and most
importantly, improves cognition.
ECAD primarily signifies atherosclerosis of the carotid bifurcation, where plaque accumulation is uniquely
prevalent compared to other cerebrovascular locations. Carotid arteries play a major role in brain physiology
because they bring the majority of blood and nutrients to the brain. We hypothesize that mechanisms of ECAD
contribution to Alzheimer’s disease and cognitive dysfunction are likely multifactorial and include embolic
phenomena, decreased blood flow, and endothelial activation/inflammation. Interplay between these modifiable
factors and non-modifiable risks (ie, age, sex and ApoE status) likely contribute to neurodegeneration that can
lead to cognitive dysfunction. Our Aims 1 and 2 use cross-sectional studies to evaluate potential mechanisms of
ECAD contribution to AD-related brain structure and function changes. Subject evaluation includes
neurocognitive testing and quantification of MRI-defined structural parameters, WML accumulation, Alzheimer’s
disease blood-based biomarkers, and systemic, cerebral and carotid markers of inflammation. Aim 3 employs a
prospective, controlled cohort study evaluating the treatment of ECAD with CEA to determine which patients
show improved cognitive function (responders) and what factors are drivers of this response.
This project will define quantifiable measures of brain structural changes leading to neurodegeneration and
cognitive dysfunction in subjects with ECAD. This should further build the impetus for clinical trials that change
management of patients with ECAD. In addition, our study offers the exciting opportunity to reveal novel insights
of early Alzheimer’s disease risk and specific mechanisms of vascular contributions. Understanding the unique
contribution of ECAD to AD/cognitive dysfunction risk is particularly compelling because effective
treatments exist for ECAD yet are not currently offered for the treatment/prevention of cognitive
dysfunction.

Public health relevance
PROJECT NARRATIVE This project aims to understand the contributions of extracranial carotid artery disease (ECAD) to brain health and Alzheimer’s disease (AD) risk. Using cross-sectional and prospective longitudinal studies, we will attempt to identify: 1) which early AD-specific pathological changes are associated with ECAD, 2) mechanisms of ECAD effects, and 3) whether ECAD-specific treatment improves/prevents relevant outcomes. This will help elucidate vascular contributions to AD risk and has the potential to greatly benefit two large patient populations: those with ECAD and those at risk for AD, which we hypothesize overlap more than is currently appreciated.